Network-Targeted Neuromodulation for Nicotine Dependence in Schizophrenia

PROJECT SUMMARY
Tobacco use is the top preventable cause of early mortality in schizophrenia, leading to a 20-year decreased life
expectancy compared to the general population. Current smoking cessation treatments are derived from people
without psychosis and are significantly less effective for people with schizophrenia. We used a data-driven,
agnostic approach to identify a schizophrenia-specific circuit of nicotine dependence (the Default Mode Network,
DMN) then tested pharmacologic and neuromodulation interventions on this circuit. We observed craving was
bidirectionally mediated by DMN connectivity: 1) nicotine administration (which reduces craving) decreased DMN
connectivity in schizophrenia, while 2) a single session of intermittent theta burst stimulation (iTBS), which
increases connectivity, applied to a DMN node acutely increased craving in schizophrenia. This provides
evidence that 1) nicotine craving is mediated by this network and 2) this target can be engaged bidirectionally
via multiple interventions. This K23 mentored patient-oriented career development award proposes to test if
multiple repetitive transcranial magnetic stimulation (rTMS) sessions lead to enduring circuit change and reduce
nicotine craving. Our central hypothesis is that the brain circuit most effective to reduce nicotine craving in
schizophrenia is distinct from the pathway identified in a non-schizophrenia population. To test this hypothesis,
we will compare 1) DMN-targeted continuous theta burst stimulation (cTBS) to 2) iTBS targeted to the left
dorsolateral prefrontal cortex (L DLPFC), which reduces cigarette consumption and craving in smokers without
psychosis. cTBS has been shown to decrease network connectivity. By applying cTBS to the DMN, we aim to
decrease connectivity, thereby decreasing craving. We will determine if rTMS manipulates functional connectivity
and craving and if craving change correlates with connectivity change for each rTMS target. To optimize rTMS
response, we will also test if variability in rTMS response is explained by individual differences in network
controllability. The applicant is a psychiatrist with fellowship-level training in neuroimaging and rTMS for
substance use disorders in schizophrenia. Her long-term career goal is to build an independent research
program using neuroimaging to identify brain networks linked to substance use in psychotic disorders then test
neuroscience-based, network-targeted rTMS interventions in clinical trials for co-occurring substance use
disorders in schizophrenia. To accomplish these goals, the applicant requires additional training in: 1) design
and conduct of personalized network-targeted rTMS interventions, 2) individualized neuroimaging to optimize
rTMS response, and 3) clinical trials and biostatistics. Training will include formal coursework, didactics, and on-
site trainings, guided under a mentorship team of experts in network-targeted rTMS interventions in psychotic
disorders, computational analysis of networks in psychotic disorders, and clinical trials design for rTMS and
smoking cessation. Mentored training and completion of the proposed project will provide the applicant the skills
and experience necessary to launch a successful independent research career.

Public health relevance
PROJECT NARRATIVE Tobacco use is the top preventable cause of early mortality in schizophrenia, and smoking cessation treatments are significantly less effective in schizophrenia than in the general population. I determined that in schizophrenia, nicotine use is linked to disorganization in a brain network (the Default Mode Network) and used pharmacology and noninvasive neuromodulation to show that manipulating this network temporarily changes craving for nicotine. This project will determine if this network can be changed in an enduring way that leads to decreased nicotine use in schizophrenia.